Pilot Project Program

Project Summary
The Pilot Projects Program (PPP) of the Mount Sinai P30 Center on “Health and Environment Across the
LifeSpan” provides funding for “start-up” research projects targeting important environmental health science
(EHS) issues, particularly those that fit our life course theme, and research groups. The PPP is supplemented
with >$100,000 of institutional funding annually and awards an average of $397,000 (direct costs) in EHS pilot
grants annually. In this proposal we will partner with three other NIH- funded Mount Sinai P30 Centers
(Cancer, Aging, and Skin Biology) and our Clinical Translational Science Aware (CTSA) to co-fund EHSfocused
pilot grants (e.g., aging and the environment, clinical translational environmental health etc.). These
partnerships further augment EHS pilot grant funding and build new collaborations to attract researchers with
no previous EHS experience to our Center. PPP applications are peer-reviewed using NIH review criteria and
are prioritized if 1) they are likely to lead to a extramural grant, 2) if the PI is an early stage investigator; and 3)
if the proposal is a multi-PI grant with a postdoctoral fellow who pledges to use the project for a K grant
application. In the Center’s first 8 years, we distributed 78 pilots totaling ~$2.4 million. In return, these pilots
have led to 43 NIH grant applications, 19 of which are already NIH funded. We have doubled our NIEHS
overall funding from 2018 to today, and tripled our NIEHS funding since the Center was founded. The PPP
also enhances Facility Core usage and is a vehicle for career development. Our early-stage investigator (ESI)
support mechanisms have been remarkably successful, with 48 of 78 funded pilot grants awarded to ESIs.
Our Center has fueled many new cross-disciplinary pilot grant collaborations among its Members, and Pilot
Project PIs have come from multiple departments, including Genetics (Drs. Faith and Pandey), Global Health
(Dr. Vreeman), Otolaryngology (Dr. van Gerwen), Oncology (Drs. Muhammed and Lujambio), Dermatology
(Dr. Chipuk), Neuroscience (Dr. Morishita), Pediatrics (Drs. Chu, Satlin), Endocrinology (Dr. Homann),
Pulmonology (Drs. Bose and Lee), Nephrology (Drs. Nadkarni and Zhou), Population Health (Dr Benn) and
Psychiatry (Dr. Reichenberg). These PIs had no prior EHS research experience before receiving a P30 pilot
grant. The PPP Core created many of the supports that accelerated our remarkable growth over the Center’s
first 8 years. We have demonstrated our ability to leverage pilot grants for future NIH awards and to bring new
investigators into EHS. Going forward, we will increase our total outlay in pilot funding through crossdisciplinary
partnerships with other NIH funded Mount Sinai P30 Centers and our CTSA, ensuring that our
Center expands its sphere of influence across Mount Sinai, meets pressing EHS research needs and engages
researchers from multiple disciplines bringing EHS into greater local, regional and national attention.